Engaging Pacific Islanders in Mental Health Treatment Services

Abstract
Pacific Islanders are a vulnerable racial population that is greatly affected by physical health disparities such as
cancer, obesity, diabetes, and heart disease. In addition to these physical health disparities, evidence from our
NIMH R21 research reveals Pacific Islanders experience sizable mental health disparities including high levels
of untreated mental illness that we suspect may contribute to Pacific Islanders’ poor health and elevated risk of
chronic disease (e.g., cancer, obesity).
Unfortunately, although many Pacific Islanders experience high levels of mental health need, very few present
for treatment. This appears to be due to the following major treatment barriers identified in our R21: low mental
health literacy, high mental health stigma, and poor knowledge of treatment leading to misperceptions of
treatment and subsequent resistance. The proposed R34 pilot study will address this problem by creating and
pilot testing Talking Story: a novel intervention designed to promote Pacific Islander treatment seeking by using
culturally grounded strategies to overcome their major treatment barriers. Building on our R21 conceptual
model of Pacific Islander-preferred intervention strategies, Talking Story will combine lecture-based content
from current mental health evidence-based practices with innovative health communication films (called
narratives) that depict fictional stories of Pacific Islanders in treatment-related scenarios.
To build Talking Story, we will design the initial versions of the lecture content and narrative films with an
advisory council of Pacific Islander experts and a professional filmmaker. We will then conduct 2 citizens’
panels to bring together 24 Samoan adults, 24 Tongan adults, and 12 treatment providers in Los Angeles
County to discuss and shape our content and films for cultural fit and impact. Using the data from these panels,
our content will be finalized and combined into an intervention manual that will be pilot tested in a randomized
wait-list controlled trial with 24 Samoans and 24 Tongans with mental illness to gain information about the
intervention’s feasibility, acceptability, and utility; leading to full-scale randomized controlled testing in a follow-
up R01 study. Study findings will be disseminated to the Pacific Islander community via brochures and public
forums, and to the scientific community via presentations and peer-reviewed manuscripts.

Public health relevance
Narrative Pacific Islanders bear high risk for mental health and substance use disorders but rarely present for treatment due to three powerful barriers: low mental health literacy, high mental health stigma, and poor knowledge of mental health treatment. Building on a conceptual model of evidence-based strategies shaped by Pacific Islanders in an earlier NIMH R21, this R34 study will design and pilot test Talking Story: the first culturally grounded intervention to promote treatment seeking among Pacific Islanders. By combining state-of-the-art narrative films designed to increase Pacific Islanders’ mental health knowledge with culturally adapted mental health literacy and anti-stigma practices, Talking Story will be tested for feasibility and measurement in preparation for full-scale randomized controlled testing in a future NIMH R01.